Guys/Girls Opt for Activities for Life (GOAL) Trial

Abstract Inadequate physical activity and poor diet quality contribute to the high overweight/obesity (OW/O) prevalence in adolescents, aged 12-19 years, indicating a need to intervene at or before age 12. Compared with other adolescents, underserved (minority; low socioeconomic status) adolescents in urban areas exhibit more unhealthy behaviors that increase their risk for obesity and related cardiovascular disease (CVD). Guided by Self-Determination Theory and the Information-Motivation-Behavioral Skills Model, the novel 16-week Guys/Girls Opt for Activities for Life (GOAL) intervention includes 3 components: 1) After-school GOAL Club: 26 120-minute events (2 days/week) for boys and girls that incorporate physical activity and healthy eating and cooking; 2) Three parent-adolescent dyad meetings to empower dyads about physical activity and healthy eating and cooking; and 3) GOAL social networking website so parents can motivate each other to help their adolescents increase physical activity and diet quality. The purpose of this 5-yr group randomized trial (unit of assignment is school) is to evaluate the effect of GOAL on decreasing CVD risk factors (high % body fat, OW/O, low CV fitness), improving quality of life (QOL); and increasing motivation, self-efficacy, and social support to increase MVPA and diet quality among underserved adolescents (5th–7th grade) having BMI z-score ?0. The long-term goal is to improve the CV health of underserved adolescents to decrease health disparities, a major priority of NHLBI. Eighteen schools will be randomly assigned to receive either GOAL (n=9) or usual school offerings control (n=9) condition. Forty dyads of boys (n=20) and girls (n=20) in each school and one parent per adolescent who is willing to serve as a support person will be enrolled (720 dyads total). Analysis will be based on the intention-to-treat principle. Aims are to evaluate effect of the GOAL intervention, compared to control, on: (1) Improving % body fat (primary outcome) by ?2.5% between intervention and control adolescents with a BMI z-score ?0 from baseline (0 months) to 4 months (immediate post-intervention) and to 13 months post-baseline (9-mon. F/U); (2) Increasing secondary proximal outcomes among adolescents: MVPA (via accelerometers; min/hr) and diet quality (healthy eating index based on 3 24-hr dietary recalls) from 0 to 4 months; (3) Improving secondary distal outcomes: CV fitness (Progressive Aerobic CV Endurance Run, [15- or 20-m shuttle run]) from 0 to 4 months; and BMI, OW/O percentage, & QOL from 0 to 4 months and to 13 months; and (4) Increasing social support, self-efficacy, and motivation with evaluation of any mediating effect on adolescent PA and diet quality. An exploratory aim (parents) is to evaluate any effect of GOAL, compared to control, on: (1) Improving parents’ perceived family nutrition and PA, MVPA (via accelerometers), and diet quality (fruit-vegetable-fiber screener) from 0 to 4 months; and (2) Reducing parents’ % body fat and BMI from 0 to 4 months and to 13 months.

Public health relevance
Project Narrative The novel and theory-driven 16-week “Guys/Girls Opt for Activities for Life” (GOAL) school- and home-based intervention addresses the high overweight and obesity prevalence among U.S. adolescents and the underrepresentation of those who are underserved in prevention research. To address these vital public health priorities, a rigorous group RCT will be used to evaluate the efficacy of the GOAL intervention in improving healthy eating and physical activity and perceptions related to both behaviors, as well as anthropometric outcomes among urban, racially diverse, adolescents of low socioeconomic status. The intervention is expected to reduce cardiovascular disease risk factors among at-risk adolescents and contribute toward reducing health disparities, a major priority of the NIH and CDC Division of Adolescent and School Health.